Phosphoproteomic Analyses of Understudied Protein Kinases that affect Zebrafish Sleep

ABSTRACT
Two recent studies found that sleep and wake have opposing effects on the brain phosphoproteome. Prolonged
wakefulness results in hyperphosphorylation of many proteins in the brain, whereas sleep promotes
dephosphorylation of the brain proteome. A gain-of-function mutation in salt-inducible kinase 3 (sik3) results in
a brain state similar to that of prolonged wakefulness and is associated with hyperphosphorylation of a subset
of the proteins that are hyperphosphorylated in wild-type animals during prolonged wakefulness. These
observations suggest that protein phosphorylation may play a role in the accumulation of sleep pressure during
wakefulness that dissipates during sleep, and that this phosphorylation is mediated in part by sik3, although it is
clear that additional protein kinases are involved. However, the identity of these protein kinases remains
unknown. Based on a large (>500,000 subjects) human genome-wide association study (GWAS) that identified
many loci in the human genome that are associated with human sleep variation and sleep disorders, we are
performing a targeted genetic screen using zebrafish to identify the relevant gene in each locus. Four of the
genes targeted in this screen are listed as “Understudied Proteins” as part of the NIH “Illuminating the Druggable
Genome” (IDG) project. We have found that loss-of-function mutations in the zebrafish ortholog of one of these
human genes results in decreased sleep. We will test the hypotheses that (1) the three other IDG genes targeted
in the screen also regulate sleep, and that (2) these genes play roles in changes in the brain phosphoproteome
that are associated with sleep or wakefulness. We will test hypothesis (1) by assaying each mutant for sleep
phenotypes using locomotor activity and arousal threshold assays. For genes in which hypothesis (1) is correct,
we will test hypothesis (2) by characterizing the zebrafish brain phosphoproteome in response to gain- and loss-
of-function genetic perturbations of each gene. These experiments will provide the first demonstrated functions
for the IDG genes being tested, characterize effects of these protein kinases on the brain phosphoproteome,
and explore an exciting new mechanism that may underlie sleep homeostasis. Based on these experiments and
human GWAS data, this project will also reveal the basis for some of the observed variation in human sleep and
some human sleep disorders and provide new druggable targets to treat these disorders.

Public health relevance
NARRATIVE Sleep and wake states have been associated with large changes in phosphorylation of many proteins in the brain, but the protein kinases that induce these changes are largely unknown. Based on human genetic studies, we have identified four protein kinases that are “Understudied Proteins” as part of the NIH “Illuminating the Druggable Genome” project as having potential roles in regulating sleep. We will determine whether these four proteins regulate sleep in zebrafish and characterize the brain phosphoproteome in response to loss- and gain- of-function perturbations of these genes.